Signals and Mechanisms Underlying the Benefits of Exercise

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Signals and Mechanisms Underlying the
Benefits of Exercise, organized by Drs. Jeffrey Horowitz, Laurie Goodyear and Karyn Esser. The conference
will be held in Santa Fe, New Mexico from January 14-17, 2023.
A physically active lifestyle is known to be a key component for sustained overall health and well-being; exercise
is also used often as a first-line approach for the treatment and/or prevention of many chronic diseases. Despite
the overwhelming evidence supporting the health benefits of exercise, the molecular, cellular, tissue, and
systemic responses to exercise that underlie these beneficial health effects remain unclear. Deepening our
understanding about the mechanistic connections between exercise and health is critical for optimizing lifestyle
programs to improve human health across an individual’s lifespan. This Keystone Symposia conference will
present new findings addressing the impact of circadian rhythms, sleep, and epigenetics, as well as sex-specific
differences on the adaptive responses to exercise. Sessions at this conference will also address the effects of
exercise on inflammation, brain function/cognition, and crosstalk between different tissues. The overall goal of
this conference is to provide a forum for scientists to discuss the complex responses to exercise, thereby
advancing our knowledge about the many health benefits of exercise. In addition, this conference will provide
an environment to foster connections and potential future collaborations for the attendees.

Public health relevance
PROJECT NARRATIVE The benefits of exercise for overall health and wellness have been well known for years, and exercise is often used as an early intervention to combat many chronic disorders such as diabetes and obesity. However, there remain many gaps in our understanding of the factors underlying the beneficial health effects of exercise, knowledge that will be critical in optimizing lifestyle programs to improve human health. This Keystone Symposia conference will provide an outstanding forum to gather researchers across the field and foster collaborations for next-level discoveries that will direct future clinical treatments and disease prevention efforts.